Microbiota and Extracellular Matrix Interactions that Drive Host Tissue Remodeling

PROJECT SUMMARY
Knowledge about the human microbiome has increased exponentially in the last twenty years, leading to its
association with a wide variety of conditions and diseases. However, many of the mechanisms underlying the
relationships between microbes and their human hosts have not been elucidated, particularly at the tissue level.
The human extracellular matrix (ECM) provides important structural and biochemical cues for the development
and homeostasis of all human tissues. Extensive ECM remodeling is a prominent feature of several diseases
linked to human microbiome dysfunction including pulmonary cystic fibrosis, inflammatory bowel disease, and
cervical cancer. Yet, regardless of tissue or body part, host cells (e.g. fibroblasts, macrophages, and neutrophils)
are considered the primary drivers of ECM degradation, even though human-associated microorganisms are
known to secrete active proteases. Thus, crucial ECM-microbiome interactions should be included in existing
paradigms of host ECM remodeling. To address this important knowledge gap, our lab develops in vitro and ex
vivo models using biomaterials and tissue engineering strategies to explore the fundamental mechanisms behind
ECM-microbe interactions. We hypothesize that commensal microbiota can degrade human ECM and that
ECM remodeling, in turn, alters host cell behavior. The proposed research program will initially answer three
key questions: 1) What environmental conditions enable bacterial degradation of host ECM? Our
preliminary data demonstrates that commensal bacteria grown in complete growth medium can degrade
individual ECM components in vitro. Because environmental factors influence bacterial metabolism, we will
explore how factors such as pH, and nutrient source impact ECM degradation by gut and vaginal bacterial
species. 2) How do human-associated bacteria remodel host ECM? In parallel to question 1, we will use
metaproteomics and inhibition studies to identify the specific proteases and carbohydrate degrading enzymes
involved in ECM degradation. Additionally, we will develop an ex vivo tissue culture model to characterize the
extent of bacterial ECM remodeling. 3) What are the consequences of microbiota-driven ECM remodeling
for host immune cells? Because the ECM regulates cell behavior, we will test the hypothesis that ECM modified
by the microbiome impacts host cell function. We will generate in vitro biomaterial platforms that capture the
properties of native ECM and incubate them with microbiota culture supernatant. We will then expose innate
immune cells to the remodeled matrices and evaluate their phenotype. This ESI-MIRA award will enable my
group to discover interactions between bacterial microbiota and host ECM, shedding light on the microbiome’s
underexplored contributions to tissue maintenance and dysfunction. Ultimately, the vision for my research
program is to determine the impact of the human microbiome on ECM remodeling and leverage this new
knowledge to develop novel diagnostics and therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Alterations in the human microbiome have been associated with a wide variety of diseases; however, the specific mechanisms that allow microbiota to regulate host health have not been fully elucidated. This work will explore the microbiome’s role in tissue homeostasis by investigating how commensal bacteria degrade ECM, identifying microbial enzymes involved in this process, and understanding the impact of remodeled ECM on innate immune cell behavior. In the long term, these studies will lead to the identification of mechanisms that link human microbiota to ECM dysregulation and inflammation, potentially paving the way towards novel diagnostic and therapeutic approaches.